Nonlinear wave interactions in the cochlea and their application to sound processing

Project Abstract/Summary
The mammalian cochlea achieves its outstanding performance characteristics by including a physiologically vul-
nerable active process that strategically ampliﬁes waves as they propagate through the cochlear spiral. As a
result of this spatially coordinated and nonlinear wave ampliﬁcation, the cochlear response at one characteristic-
frequency location largely depends upon the physiological status and the response in more basal regions. In
response to complex sounds, waves of different frequency nonlinearly interact along the cochlea, mutually sup-
pressing one with the other. In contrast to a bank of independently operating ﬁlters commonly used to depict
cochlear function, the responses of distinct “cochlear ﬁlters" are strongly coupled by nonlinear wave interactions.
Although nonlinear wave interactions play a major role for the cochlea response, their role for encoding complex
sounds in the auditory periphery—and consequently their contribution to central auditory mechanisms—is poorly
understood and largely ignored.
Understanding nonlinear wave interactions is hence essential to establish how the cochlea encodes eco-
logically relevant sounds and the role of the auditory periphery for sound perception. Because nonlinear wave
interactions depend upon the health of the ear, understanding these interactions is fundamental also to establish
how cochlear impairment affects the peripheral representation of complex sounds. Further, because even mild
sensorineural hearing loss greatly degrades behavioral performance in acoustically challenging situations, it is
likely that nonlinear wave interactions underlie unexplored mechanisms for the outstanding performance of the
healthy ear.
My project will tackle these issues by: (i) deriving from the experimental data a cochlear model that reproduces
accurately nonlinear wave interactions in laboratory animals (Aim 1.a) and humans (Aim 1.b); (ii) testing the
hypothesis that nonlinear wave interactions underly beneﬁcial mechanisms to encode sounds in acoustically
adverse situations (Aim 2.a), and (iii) determining how and with what limitations the effects of nonlinear wave
interactions elucidated in this project are accounted for by popular computer models of the auditory periphery
(Aim 2.b). The results of this project will not only challenge and improve the current understanding of cochlear
function for hearing, but will also ﬁnd natural application in improving models of hearing impairment, and in
determining novel cochlear-inspired strategies to improve the performance of assistive hearing technology.

Public health relevance
Project Narrative The proposed project will elucidate and model the effects of nonlinear outer-hair-cell based ampliﬁcation—whose impairment underlies the most common forms of sensorineural hearing loss—for the representation of complex sounds in the healthy cochlea. Motivated by the discrepancy between the experimental data and the common understanding of the role of the auditory periphery for central auditory mechanisms, the goal of this project is to understand the cochlear mechanisms responsible for the outstanding performance of the healthy ear in acoustically adverse situations. Results of this project will ﬁnd direct applications to improving models of hearing loss and to developing new sound processing paradigms for assistive hearing technology.